EFFECTS OF CAPTOPRIL AND NIFEDIPINE ON GLUCOSE METABOLISM IN DIABETICS

The purpose of this study is to compare the effects of captopril and nifedipine on insulin sensitivity and blood pressure control in diabetic subjects.